A non-viral nanoparticle gene therapy delivery platform for treating Cystic Fibrosis and other diseases

SUMMARY
The use of gene therapy for chronic lung diseases, such as cystic fibrosis, has increased dramatically since the
early 2000s, but a safe, long-term delivery method remains missing. Despite a highly safe profile with partial
therapeutic effects after successful delivery in CF patients, the gene transfer efficiency, in terms of transfection
per particle, remains limited when using viral-based delivery systems. Genexys has developed a modular non-
viral gene transfer platform that directly addresses the limitations of current CF gene therapeutic strategies. The
technology is a DNA and RNA nanoparticle platform capable of holding large genes combined with uptake
enhancers that inhibit proteins that limit gene transfer to targeted cells. Our foundational work has demonstrated
our DNA nanoparticle technology successfully delivers therapeutic loads of the cystic fibrosis transmembrane
conductance regulator (CFTR) in cell culture, animal models, and human subjects. Our unique proprietary
enhancer library allows our non-viral system to overcome the gene transfer limitations of our competitors. This
library of enhancer molecules is hypothesize to work through Nucleolin (NCL), an essential protein for DNP-
based cell surface receptor that facilitates gene membrane transfer and nuclear trafficking. This project further
develops our non-viral nanoparticle gene therapy system in an in vitro and in vivo context. We aim to demonstrate
transgene delivery with enhancers restores primary function in human bronchial epithelia cells and can overcome
muscus inhibition in mouse FDA IND-enabling studies. We will also explore different delivery formulations. The
deliverables will include an established efficacy of this product in a commercially available gene therapeutic, and
that this revolutionary technology can be available to all CF patients needing advance treatment options.

Public health relevance
NARRATIVE The standard of care is ineffective for a subset of the CF patient population. Direct gene modulation via gene therapy, despite a highly safe profile with partial therapeutic effects after successful delivery in CF patients, remains limited due to viral-based methods. This proposal intends to develop a non-viral gene therapy method to treat cystic fibrosis that will move a novel non-viral platform one step closer to FDA IND filing and commercialization.